Spatially multiplexed biogel nanosensors with boron-doped diamond microelectrode arrays for HIV self-testing

Project Summary
The clinical studies demonstrating that when people maintain undetectable levels of viral loads, HIV cannot
transmit provided an exciting new direction for HIV management. A central part of HIV health care will be to
develop the technology required for home testing of HIV viral loads similar to diabetes management. There are
several requirements for such a home test. First, sample preparation of virus must cleanly isolate virus-laden
plasma without lysing white blood cells or require any lab equipment. Second, the test must store reagents on-
chip at ambient conditions over long periods. Third, the test must provide accurate and ideally, semi-quantitative
information without requiring extensive manipulation, training, or expensive instrumentation. Current diagnostics
cannot meet these requirements. The highest value test is nucleic acid amplification but the enzymes and buffers
require cold chain storage, trained personnel, and frequently, fluorescence-based instrumentation. Antibody-
based tests for viral capture on lateral flow are hampered by lower analytical sensitivity and specificity values,
are not quantitative, and are hampered by protein rather than nucleic acid-based manufacturing infrastructures.
Here we propose the integration of our novel biogel nanosensors and boron-doped diamond microelectrode
arrays to directly provide actionable, semi-quantitative, HIV viral load information for the home user. Our hydrogel
encapsulates and locks in NAAT tests in aqueous environments without oil or manufacturing additional
compartments. The gel provides safe, on-chip storage of reagents and critically, is printable for rapid fabrication
of arrays for digital quantitation. The gel is also specifically positively charged to attract and concentrate viral
genomes from the raw sample which would improve the LOD95. In our proposed platform, a boron-doped
diamond microelectrode underlies each spot in the array. This will provide an individual, electrochemical readout
for every spot which can be interpreted in a digital format for potential quantification. With this platform, the user
simply adds blood from a fingerstick and uses a membrane to separate out the plasma. A second wicking
membrane with lysis reagents delivers viral genomes to the biogel nanosensor array via lateral flow. Together,
the ease of use, on-chip storage, creation of a digital electrochemical readout, and compatibility with
manufacturing infrastructures to keep costs low yields a promising, viable platform for HIV management at home.

Public health relevance
Project Narrative The proposed work is focused on the advanced integration of HIV NAAT locked and stored in hydrogels and detected electrochemically with boron-doped diamond sensor microelectrode arrays. Each spot will individually readout amplification in what is essentially a novel, digital, electrochemical lateral flow assay. The successful completion of this project will deliver a demonstrator platform for the semi-quantitative readout of HIV viral loads at home.